Unravelling the mechanisms of virus host species jump

Project Summary
Uncovering the mechanisms enabling the cross-species jumps of viruses that happen in nature is essential for
our understanding of viral spillovers, most notably those that can result in severe disease outbreaks, for example,
the coronavirus SARS-CoV-2 pandemic and Mpox (monkeypox) epidemic. Therefore, studying the evolution of
viruses that cause species jumps is essential. Myxoma virus (MYXV), a leporipoxvirus, is nonpathogenic in its
evolutionary host (Sylvilagus sp.) but was highly lethal (causing myxomatosis) immediately after it leaped into
European rabbits (Oryctolagus cuniculus) in the late 19th century. The introduction of MYXV to control feral
European rabbit populations in Australia and Europe in the early 1950s presents the best-documented field
example of host-virus co-evolution. In 2018, a new natural MYXV variant was identified in Iberian hares (Lepus
granatensis) in Spain, causing a myxomatosis-like disease in hares and wild European rabbits. Between 2018
and 2020, the disease became endemic, with an estimated mean mortality rate of 55% in hares. This newly
emerged MYXV variant, named MYXV Toledo (MYXV-Tol) or hare MYXV (ha-MYXV), has acquired a novel
insertion of four viral genes “cassette” of ~ 2,800 bp within the M009L gene. The MYXV-Tol genome also includes
three disrupted genes (M009L, M152R, and M036L). We recently reported that the C7-like host range gene
M159-Tol present in the MYXV-Tol recombination cassette is essential for infection and replication in hare cells,
suggesting that M159-Tol may be required for the extreme pathogenicity in hares. Since MYXV-Tol is also
isolated from wild European rabbits, we studied the pathogenicity of MYXV-Tol in European rabbits and
compared it with MYXV-Lau and the C7-like host range mutant vMyxTol-M159KO. Our results, for the first time,
demonstrate that the natural MYXV variant MYXV-Tol has adapted to cause a uniquely different lethal disease
and pathogenicity in European rabbits compared to typical myxomatosis caused by MYXV-Lau. Surprisingly, the
deletion of M159-Tol had minimal or no effect on the disease progression and pathogenicity of MYXV-Tol in
rabbits. Thus, M159-Tol may have adapted hare-specific host tropism functions, and we hypothesize that the
additional newly acquired viral genes or the disruptions in some of the ORFs have enabled MYXV-Tol to cause
a novel lethal disease in Iberian hares and European rabbits. In this application, we propose investigating
the biological mechanisms and genetic changes in the MYXV-Tol that facilitate species leaping and
cause novel pathogenicity and disease in European rabbits. Aim 1: Elucidate the biological mechanisms
of how MYXV-Tol is causing a novel lethal disease in European rabbits. Aim 2: Define the genetic
changes in MYXV causing the novel disease in European rabbits. This information will be essential for future
identification of the unique cellular targets for MYXV-Tol. This R21 proposal will enable us to understand how
natural genetic changes in poxviruses allow species leaping and sometimes cause a new lethal disease in a new
host.

Public health relevance
Project Narrative This study will investigate the biological underpinnings driving myxoma virus adaptation and disease manifestation in hares following a species jump from European rabbits. This poxvirus model system will use both in vitro and in vivo approaches to determine the biological mechanisms and characterize the genetic changes that enabled a new natural myxoma virus variant causing a lethal myxomatosis-like disease manifestation in wild European rabbits and Iberian hares. Further, this study will provide valuable information for a broader understanding of zoonotic viral spillover of other poxviruses, such as the host species jump of monkeypox virus or cowpox virus into humans.